Cancer Prevention and Control Research Training and Career Development Program

The University of Texas School of Public Health proposes to transition our highly successful, longstand-
ing R25T, Cancer Control Research Training and Career Development Program for doctoral students and
postdocs to the T32 mechanism. Our long-term goal is to reduce cancer morbidity and mortality by ex-
panding the quality and impact of cancer control research and the reach, implementation, and mainte-
nance of effective programs in communities, especially those underserved. Our objective, to increase the
number of cancer control scientists with cutting edge research and analytic skills and a commitment to
reducing disparities, addresses this goal. We prepare junior scientists from public health disciplines to
conduct a wide range of cancer control research, emphasizing skills in participatory research, multilevel
cancer control intervention development and adaptation, evaluation, and dissemination and implementa-
tion science. We build knowledge and skills in forging partnerships and team science to develop trans-
disciplinary and translation research that can have the greatest impact on reducing cancer disparities.
The unique curriculum features specific competencies; detailed, complementary expectations of trainees,
mentors, and Program directors; a tested format and rubrics for a year-round interdisciplinary seminar led
by experienced junior and senior faculty; individualized development plan templates; tables for tracking
publication development; and an annotated on-line career development resources. Outstanding mentors
and co-mentors provide a rich portfolio of funded projects and data heavily weighted toward underserved
groups, including Hispanic/Latinos, African Americans, sexual minorities, and low income/safety net clinic
populations. Topics span HPV vaccine, tobacco use and exposure, obesity, physical activity, sexual be-
havior, cancer screening, and survivorship. We provide trainees with premier research skills such as so-
cial network and geo-spatial analysis, Baysian approaches to clinical trials, community participatory meth-
ods, multilevel intervention design, ecological momentary assessment, and dissemination and implemen-
tation research to enable them to tackle the multilevel, multidimensional, factors that influence cancer.
We will maintain 4 doctoral positions to take strategic advantage of our strength in training doctoral stu-
dents who can move to other NCI postdoc training programs; 4 postdoc positions will launch trainees into
faculty positions. By the end of the current R25T cycle we will meet our goals, graduating 8 predocs and
6 postdocs, with 2 more predocs and 3 postdocs with <1 year to finish; 1/3 are Latino or African Ameri-
can; of 9 who completed training 8 are in postdocs or research positions doing cancer-related research.
In Years 26-30 with a multi-PI leadership team led by an accomplished Latina investigator, we propose to
train 17 cancer prevention scientists, ~1/3 underrepresented minority, to address cancer disparities
through collaborative research emphasizing dissemination and implementation science.

Public health relevance
PROJECT NARRATIVE Preventing cancer and finding it early, when it can be treated easily, is an important priority in the U.S., where cancer is the second leading cause of death. Our Cancer Prevention Research and Control and Career Development Program at the University of Texas School of Public Health is applying for an additional 5 years of funding to continue a training program for doctoral students and post-doctoral fellows from public health disciplines to learn to work together on programs to reduce the number of people in the U.S. who get cancer or who die from cancer.